Enabling comprehensive diagnosis of sub-acute infection in chronic respiratory disease via high sensitivity next generation sequencing

ABSTRACT
Sub-acute lung infections are increasingly recognized as drivers of poor symptom control among a subset of
individuals with chronic lung disease, estimated to be more than 2 million in the US for Asthma and COPD
patients. When these sub-acute infections are diagnosed and treated appropriately, chronic lung disease
patients can convert from moderate/severe to a milder disease phenotype, requiring lower medication to achieve
better health at a significantly lower cost. Current gold-standard diagnostics for sub-acute infection rely on
decades-old technology that can take weeks to complete, have limited sensitivity, and are limited in the type and
number of microbes that can be screened by a single test. Thus, a critical gap exists due to the inability of current
diagnostics to comprehensively and accurately detect microbial pathogens in low-burden clinical samples, which
is a significant barrier to improved clinical outcomes in chronic lung disease. We have thus developed a
comprehensive next generation sequencing (NGS) panel for detection and identification of microbes. Our Phase
I studies have demonstrated the feasibility of our diagnostic tool for application to subclinical respiratory
infections and its superiority to both microbiological and molecular approaches to diagnosis. Our NGS
diagnostics (Dx) panel is a significant technological innovation over current methodology; the Dx panel utilizes
samples directly from the patient (rather than relying on cultures), provides greater sensitivity than qPCR or
meta-genomic sequencing approaches and screens for the presence of tens of thousands other microbes in a
single assay. These features are possible due to our Dx panel design in addition to proprietary laboratory and
analysis workflows. The long-term goal of this project is to provide novel clinical tools for the detection of low-
burden microbial infections driving disease pathology, symptomology, and exacerbations in chronic lung disease
populations. In this Phase II, we will develop a data integration system to 1) deploy our diagnostic test in
healthcare organizations to drive physician adoption, 2) build data and apply algorithms necessary to expand
the impact and value-based reimbursement of our assay. Our Aims are to 1) develop a cloud-based commercial
software system for data receipt, storage, analysis and clinical reporting at scale, 2) integrate our software
system into the clinical workflow at our clinical partners, and 3) develop a web-based visualization portal for test
results and build the infrastructure for use of advanced statistical learning algorithms. This integrated system will
drive the development and application of personalized medicine approaches for diagnosis and treatment
guidance currently missing in chronic lung disease. The total market for this diagnostic is the set of chronic lung
disease patients with uncontrolled symptoms who could be screened for sub-acute infections. Our competitive
advantages include improved sensitivity, comprehensive microbe detection, streamlined analysis, and treatment
effectiveness insights within a single assay.

Public health relevance
PROJECT NARRATIVE Low-level lung infections that do not exhibit the usual symptoms of a pathogen can be a major source of uncontrolled disease in patients with certain lung conditions, like asthma and COPD. Patients with uncontrolled disease experience significant medical costs, hospitalizations and negative impact on quality of life. The goal of this project is to develop the computing system necessary to make available a new diagnostic test for low-level lung infections in patients with a chronic lung disease, thereby providing treatment guidance to achieve disease control for the patient.